Developmental Research Program

ABSTRACT – Developmental Research Program
The Developmental Research Program (DRP) is a critical component of the Duke SPORE in Brain Cancer,
supporting (1) pilot research projects with translational potential relevant to brain tumors and (2) the
participation of experienced investigators from other fields to work in brain tumor research. Projects are
encouraged to test novel concepts and paradigms that bring new approaches into the field to advance
understanding of brain tumor biology and improve brain tumor diagnosis, treatment, and/or prevention. The
DRP will support two to three promising projects each year, with the option of renewed funding for one
additional year with excellent progress. Projects that have a strong likelihood of either developing into full
SPORE projects or projects that can receive funding as independent research projects (e.g., R01s) will be
specifically targeted for support. Both individual investigator and collaborative research are eligible. The
Specific Aims of this DRP are: 1) To identify and support meritorious basic, translational or clinical research
projects that have a high probability of impacting the diagnosis, treatment or prevention of brain tumors; 2) To
attract new, outstanding and experienced investigators, currently not working on brain tumors, to pursue brain
tumor research; 3) To facilitate collaborative research to test novel concepts and paradigms relevant to brain
tumor biology, diagnosis, treatment or prevention, and 4) To evaluate progress on funded projects and
facilitate their evolution into full SPORE projects or into independently funded projects. Through these Aims,
the DRP helps to ensure success in the Duke Brain SPORE's charge to translate research findings from the
bench to the bedside of brain tumor patients.

Public health relevance
PROJECT NARRATIVE – Developmental Research Program The Developmental Research Program is a critical component of the Duke SPORE in Brain Cancer and meets the NIH requirement for all SPOREs. It will take maximum advantage of new research opportunities in brain tumors, attract new outstanding investigators and collaborators to the field of neuro-oncology, provide support for novel research, and serve as a source of new translational projects for the SPORE. By providing support for novel neuro-oncology research, this program will accelerate discovery and expand the breadth of research seeking to improve outcomes for patients with primary brain tumors.